Validation of the joint-homing and drug delivery attributes of novel peptides in a mouse arthritis model

Rheumatoid arthritis (RA) is a chronic debilitating disease affecting over 1% of Americans. Women are affected
about 3 times more often than men. RA also constitutes a major health problem among the U.S. Veterans. The
Veteran population is aging, and the number of women serving in the military is gradually increasing. In
addition, military personnel in combat zones are exposed to extreme stress and toxic substances in different
forms. All these factors may directly or indirectly influence host immunity and induction/aggravation of RA. The
pain, discomfort, lost working days, and disabilities caused by RA can adversely affect Veterans’ quality of life
in many ways, as well as impose heavy cost of healthcare and rehabilitation. Therefore, studies advancing new
modalities of treatment of RA are highly relevant to the U.S. Veterans. Using the rat adjuvant-induced arthritis
(AA) model of human RA, we developed a peptide-guided targeted liposomal drug delivery system for arthritis
therapy. For this purpose, we used a novel joint-homing peptide ART-2 to guide liposomes entrapping
dexamethasone (DEX) to arthritic joints of rats. Peptide-guided liposomal DEX was more effective in
suppressing arthritis in rats than untargeted liposomal drug or free drug. Importantly, the increased efficacy of
the ART-2 liposomal group was not associated with concurrent increase in systemic toxicity. Thus, peptide-
guided liposomal drug delivery improved the therapeutic profile (benefit/risk ratio) of DEX over the other two
modalities. However, unlike inbred rats (used in the rat AA model), which are genetically homogeneous (same)
and generate immune response mainly to heat-shock protein 65 (Hsp65), RA patients have diverse genetic
make-up and generate immune response to both Hsp65 and type II collagen (CII). Therefore, we need to
validate our current findings from the rat AA model in an independent second model, the mouse collagen-
induced arthritis (CIA) model, which differs in genetics and certain disease parameters from the AA model.
This validation will be the first step to de-risk the translational application of this technology to RA patients
before undertaking further development and evaluation to meet the criteria of an investigational new drug (IND)
for the FDA. This is significant because the Veterans Affairs (VA) has filed a non-provisional patent on the use
of peptide ART-2 for arthritis therapy with the U.S. Patent and Trademark Office. The AA and CIA models of
arthritis share some (but not all) features with human RA, but they also differ in a few critical characteristics:
1) unlike Lewis rats (RT-1l), inbred wild type mice do not develop AA; 2) the predominant target of the T
cells/antibodies is CII in CIA, but Hsp65 in AA; 3) antibodies are pathogenic in CIA, but either show no effect or
are protective in AA; and 4) drug metabolism is different in rats and mice. We will use two CIA models: wild
type DBA/1 (H-2q) mice and “humanized” mice (H-2b) expressing HLA-DR4, one of the disease-susceptibility
genes for RA. [We will test methotrexate (MTX), the gold-standard for RA. We have successfully prepared
liposomes entrapping MTX, and pilot testing in the parent rat arthritis model (AA) showed that MTX
entrapped in liposomes is biologically active and effective in suppressing arthritis. Recently, we have completed
setting-up of the CIA model in our laboratory to validate the above findings from AA model.] The specific
aims of our study in CIA model based on peptide ART-2 and methotrexate (MTX) are: Aim 1: (a) To
validate the preferential in-vivo homing of systemically administered peptide ART-2-displaying liposomes
entrapping a near-infrared dye (Cyanine 7) to arthritic joints of mice with CIA; and (b) To examine the
pharmacokinetic and pharmacodynamic aspects of liposomal MTX delivery in mice having CIA. Aim 2: (a) To
validate the comparative efficacy of MTX delivery via peptide ART-2-displaying liposomes, control liposomes,
and free drug in suppressing arthritis in CIA mice; and (b) To determine the relative multiorgan toxicity of these
three drug delivery modalities to assess their comparative therapeutic efficacy/toxicity profiles. We believe that
with appropriate validation, this technology can be adapted and further refined for use in Veterans with RA.

Public health relevance
Rheumatoid arthritis (RA) is a debilitating disease of the joints that affects over 10 out of 1000 Americans, including the Veterans. Further, the prevalence of RA is much higher in women than in men. This is of special relevance to women serving in the military. The aging Veterans constitute another group to bear the brunt of RA. The suffering and disabilities caused by RA impose a huge financial burden on the healthcare and rehabilitation of Veterans. Many potent drugs are available for the treatment of RA; but their prolonged use is associated with severe adverse reactions because these drugs that are given orally or by injection are distributed to all organs of the body. We propose targeted drug delivery to the joint as a better alternative. We reported that an arthritis drug entrapped in liposomes that displayed a novel joint-homing peptide (ART-2) on their surface was more effective than other modes of treatment in a rat arthritis model. We now plan to validate these findings in a different (mouse) model of arthritis to de-risk the technology for translational studies in RA.